Nutrient-dependent regulation of neural stem cell proliferation and neural circuit formation

PROJECT SUMMARY
We are seeking to acquire supplemental funds to support the purchase of an incubator that will
be used in our research that is currently funded by a R35 award. Our current R35 is aimed at
uncovering genetic and molecular mechanisms that regulate neural stem cell proliferation
decisions in response to dietary nutrient availability and the nutrient-regulated neuronal circuitry
that controls these decisions. We use Drosophila melanogaster as a model system. In order to
use Drosophila in a laboratory setting, a temperature, humidity, and light/dark cycle controlled
incubator is needed to house the animals and for developmental staging experiments.

Public health relevance
Project Narrative: Neurodevelopmental disorders, including microcephaly and autism, as well as neurodegenerative diseases, including Alzheimer’s, and cancer result in significant human suffering and impose significant annual costs on the US health care system and society as a whole. This proposal seeks to understand how diet influences neural stem cell proliferation decisions during development. Neural stem cells are the cells that make all the neurons in the brain.